The Underlying Mechanisms of Visual Impairment and Myopia in Prematurity

PROJECT SUMMARY
The long-term goal of this project is to determine the neuronal and vascular mechanisms of visual impairment
and myopia resulting from prematurity in order to develop preventive and therapeutic strategies. Prenatal and
early postnatal vertebrate retinas generate correlated spontaneous neuronal activity, termed “retinal waves,” that
are essential for normal neuronal development and vision. Premature retinal wave termination may contribute to
preterm birth-associated vision problems and refractive errors. Preterm birth, in combination with postnatal oxy-
gen therapy, can also cause retinal vascular complications known as retinopathy of prematurity (ROP). ROP is
closely associated with incurable visual impairment and myopia in premature infants.
The cellular and molecular mechanisms underlying the pathogeneses of eye disorders related to ROP and the
early retinal wave activity termination are not yet well defined. Our objectives in this project are to define how
spontaneous retinal waves mediate ocular growth before visual experience and how oxygen-induced retinopathy
(OIR) causes vision impairment and myopia. Our preliminary data demonstrated that cholinergic retinal waves
generated by starburst amacrine cells (SACs) can excite dopaminergic amacrine cells (DACs), the sole source
of ocular dopamine—an ocular development regulator. We hypothesize that cholinergic waves drive normal eye
development via dopamine signaling and that suppression of this pathway will disrupt normal ocular growth. In
Aim 1, we will test this hypothesis by identifying the cholinergic wave–dopamine signaling pathway and
assessing how this pathway impacts ocular growth.
In addition, we have found that, in an OIR animal model, AII amacrine cells (AII-ACs) and DACs—two classes
of inner retinal neurons that contribute to scotopic and photopic vision, respectively—were substantially lost. We
hypothesize that the loss of AII-ACs and DACs in OIR causes myopia. In Aim 2, we will test this hypothesis by
determining the relative contributions of AII-ACs and DACs to OIR-induced myopia and assessing the impact of
OIR-induced visual impairments on myopia development.
Expected outcomes include determining how retinal waves influence dopamine signaling to mediate ocular
growth and how oxygen treatment perturbs the rod and cone signaling systems through the loss of retinal
interneurons to cause vision loss and the development of myopia. The broader impact of this work on
understanding the causes and mechanisms of preterm vision impairment and myopia in children will enable the
rational discovery of new therapeutic interventions.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because preterm birth and oxygen therapy in premature infants causes incurable vision impairment and myopia. Results from the study will advance our understanding of why vision problems and myopia of prematurity occurs in almost 1 of every 10 infants born in the United States. Our ultimate goal is to develop preventive and therapeutic strategies to preserve vision in premature infants.